Developing Inhibitors of Seasonal and Pandemic Influenza Viruses

Summary
Influenza viruses are a leading cause of human disease due to respiratory viral infection worldwide. It is the
overarching objective of this project to advance prodrug conjugates of 4’-fluorouridine (4’-FlU), a novel
pyrimidine analog with confirmed broad oral efficacy against influenza viruses, and at least one non-nucleoside
inhibitor of the influenza virus polymerase complex, to the stage of formal preclinical development and
assembly of an investigational new drug-enabling package. The project design is driven by our underlying
hypothesis that effective next-generation therapeutics for the treatment of influenza must be orally available,
display a broad indication spectrum against influenza virus isolates of human, avian, and swine lineages, and
ideally cover both influenza A (IAV) and B (IBV) viruses. These product profile demands are derived from the
clinical burden imposed by the diverse spectrum of seasonal influenza viruses, the pandemic potential arising
from spillover of zoonotic avian viruses into the human population, and current FDA recommendations that
recognize outpatient adults suffering from seasonal influenza as the primary patient population for initial clinical
testing. These developmental objectives are best met with direct acting therapeutics, since host-targeted
antiviral therapies, although often tantalizingly broad in indication range, are prone to unacceptable side effects
that are incompatible with the primary patient group pursued.
In previous work underpinning this program, we have demonstrated broad-spectrum antiviral activity of 4’-FlU
in cultured cells and animal infection models against a clinically significant panel of RNA viruses. Against the
influenza virus indication, 4’-FlU has confirmed oral efficacy against seasonal, pandemic, and highly
pathogenic avian influenza viruses in rodent and non-rodent models. The compound triggers immediate chain
termination of the influenza virus RNA-dependent RNA polymerase (RdRP) complex and carries a high barrier
to viral resistance. In preparation of clinical development, we have generated prodrug conjugates of 4’-FlU to
optimize delivery across the gastrointestinal epithelium. To broaden our influenza virus RdRP inhibitor portfolio,
we have identified a set of non-nucleoside RdRP inhibitors in a large-scale high-throughput screening
campaign that will be advanced simultaneously as companion drugs or for combination therapy in a multi-
pronged approach. To select a clinical candidate for formal development, 4’-FlU prodrug conjugates will be
subjected to de-risking efficacy and tolerability testing in relevant rodent and non-rodent animal models and
dosing paradigms explored through interfacing of dynamic PK profiles with performance in human airway
epithelium organoids (aim 1). Non-nucleoside RdRP inhibitor lead candidate scaffolds will be synthetically
developed, mechanistically characterized, and subjected to proof-of-concept efficacy testing (aim 2). Emerging
non-nucleoside leads will be queried for combination therapy with the 4’-FlU clinical candidate and the effect of
mono- and combination therapy on suppressing influenza virus transmission determined in ferrets (aim 3).

Public health relevance
Narrative Influenza viruses are a leading cause of respiratory disease due to viral infection worldwide and are responsible for over 40,000 case fatalities annually in the United States in interpandemic years. Spillover of zoonotic avian influenza viruses into the human population creates opportunity for the evolution of novel pandemic strains. Recognizing that efficacy of the existing seasonal vaccine is moderate especially in older adults, who are disproportionally at risk of severe disease, and that licensed antivirals are compromised by a low barrier to viral resistance, this project will build on a successful long-term antiviral collaboration and advance a novel orally efficacious ribonucleoside analog and a non-nucleoside companion against the influenza indication.